Therapeutic Applications of Factor VIIIa Inactivation in Hemophilia A

PROJECT SUMMARY/ABSTRACT:
This K08 Career Development Award details a five-year training program to advance Dr. Lindsey George’s
career goal of becoming an independent physician-scientist translating biochemical and molecular studies to
develop novel therapeutics for patients with disorders of blood coagulation, specifically hemophilia. During the
award period, Dr. George will continue developing her expertise in coagulation biochemistry and gene therapy,
acquire new scientific skills in mouse modeling, viral vector development and advance her translational
capabilities. Under the guidance of her mentor, Dr. Rodney Camire, these training objectives will be met by a
combination of didactic course work, participation in seminar series, research experience, and mentoring by her
advisory committee. Her advisory committee is composed of world renowned scientists with extensive mentoring
experience and diverse and complementary scientific expertise including Drs. Lawrence Brass, Mortimer Poncz,
and Beverly Davidson. The scientific proposal is aimed at addressing the current limitations of therapies for
hemophilia A. Hemophilia A is due to an inheritable deficiency in coagulation (F)actor VIII activity. The current
standard-of-care for hemophilia A is enzyme replacement therapy with intravenous FVIII infusions. There are
several novel therapeutics in various phases of clinical development that are poised to alter the current treatment
paradigm, but require mechanistic understanding to ensure safety and maximal efficacy in clinical adaptation.
Specifically, important knowledge gaps in the field relate to mechanisms by which FVIII is downregulated. This
has direct clinical relevance to understanding the safety and/or efficacy of FVIII-mimetic bispecific antibodies
that bypass natural FVIII regulatory pathways and interpreting FVIII gene therapy data wherein ectopic
hepatocyte expression may alter FVIII biology. Mechanisms regulating FVIIIa inactivation are thought to be rapid
spontaneous dissociation of the non-covalently bound FVIIIa-A2 subunit and proteolytic processing by activated
protein C; however, basic and clinical observations suggest that activated protein C has minimal physiologic
consequence in FVIIIa regulation. Dr. George’s proposal focuses on determining the mechanism of FVIIIa
inactivation and translating this understanding for purposes of improving and developing novel therapies for
hemophilia A. She has developed unique reagents and a rational approach to this timely, mechanistic question.
In Aim 1, the physiologic relevant mechanism of FVIIIa inactivation will be determined by in vitro purified systems
assays and in vivo investigation. In Aim 2, the mechanism of FVIIIa inactivation will be exploited for therapeutic
translation. Specifically, Dr. George will determine if there are differences in FVIIIa inactivation among native
endothelial versus hepatocyte-derived FVIII. She will additionally apply information learned from Aim 1 to
rationally design FVIII variants with impaired inactivation and determine their effect on hemostasis in the setting
of both gene transfer and recombinant protein through in vitro kinetic studies and in vivo gene transfer studies.
!

Public health relevance
PROJECT NARRATIVE: This proposal aims to understand the physiologically relevant mechanisms that regulate activated factor VIII inactivation. Understanding this mechanism and the role of factor VIII regulation in hemostasis has clinical applicability in multiple novel therapeutic agents currently being explored for the treatment of hemophilia A that bypass or alter factor VIII regulation. This information will be translated to create factor VIII variants with improved function as well as determine possible differences in the biology of hepatocyte expression of factor VIII following gene therapy.